Multi-ethnic Study Of Atherosclerosis - Vision Component

This project remains in an intense data analysis phase. Analyses of various ocular phenotypes, including retinal microvascular disease, have resulted in multiple published manuscripts with more in press, or are under preparation. Results from genome-wide analyses are just beginning to become available and will be a focus of future efforts. Plans to re-examine this cohort in 2010 (visit 5) have been developed, reviewed, and funded. Study protocols and other preparatory work to implement this follow-up examination have been on-going. The MESA Study has several ancillary studies one of which is this ocular component. Others ancillary studies to MESA include a lung component (funded by NHLBI) and an air pollution component (funded by the EPA). Discussions to integrate and analyze data across various study components have resulted in several paper proposals with manuscripts in process. More information about the MESA Study, including a full list of participating investigators and institutions and a complete list of publications to-date, can be found at http://www.mesa-nhlbi.org.